Research Administration and Mentoring Core

The overarching goal of the Research Administration and Mentoring Core (RAMC) is to guide the development
of an independent, nationally visible Institute for Biomolecular Targeting (bioMT) at Dartmouth, by fostering
continued growth, mentoring junior faculty, further intensifying connectivity, and enhancing its scientific impact.
During phase 1, the RAMC has led the creation of an integrated and successful environment for research,
education, and professional development. In phase 2, it will strengthen the critical mass of the center and lay the
foundation for a transition to long-term sustainability. bioMT will fund four Research Projects, two Scientific
Cores, provide supplemental start-up resources for five tenure-track faculty hires, and initiate a formal pilot
program in support of research at the basic:translational interface in cancer, airway infection and other complex
diseases. We will extend and refine our proven faculty mentoring program and will continue to forge a sense of
scientific community built around interdisciplinary, curiosity-driven exchanges. By identifying and nurturing
symbiotic connections between basic science investigations and translational research questions, these
components will advance the identification and validation of biomolecular targets to address compelling public
health needs. Scientific leadership will be provided by Director Dean Madden, PhD, Associate Director Deborah
Hogan, PhD, an Internal Advisory Committee, an External Advisory Committee, a Core Advisory Committee,
and an inclusive Faculty Council. The RAMC will provide efficient scientific leadership, fiscal oversight, and
organizational support for all bioMT components. Building on strategies successfully deployed in phase 1, it will
achieve the following Specific Aims: (1) To provide outstanding scientific leadership as bioMT members explore
new high-impact research directions; (2) To enhance career development through mentoring and educational
outreach; (3) To facilitate robust scientific communication; (4) To offer efficient administrative and fiscal support
and evaluation, providing timely and accurate reporting to bioMT and institutional leadership and IDeA Program
staff; and (5) To enrich the scientific and research environment using institutional resources. Each of these aims
will advance the bioMT mission. Inclusive, experienced leadership will expand opportunities for bioMT faculty to
pursue biomolecular target identification, validation, and development. The mentoring program will provide
expert guidance to the Project Leaders, accelerating their success as independently funded investigators. A
weekly internal seminar series, interspersed with invited talks and the yearly regional Life Sciences Symposium,
will catalyze interactions within a highly integrated scientific community. Our resources will recruit additional
faculty to the Institute, elevate their research, and increase their extramural funding success. Program leadership
has a strong track record of scientific collaboration and over a decade’s experience with multi-project awards.
Drawing on that experience, the RAMC will continue to offer excellent organizational support to the investigators
of bioMT and to advancing its success as a Center of Biomedical Research Excellence at Dartmouth.